Expression and function of CD14and TLR2/TLR4 LPS receptors

The skin actively resists bacterial infection by its excellent barrier properties and by initiating both cognate and innate immune responses. Human keratinocytes are activated by bacterial endotoxin, LPS, which is a major cell wall component of gram negative bacteria. However, little is known about keratinocyte LPS receptor expression and function. Therefore, this application will test the following hypotheses: The human keratinocytes are capable of expressing functional CDI4 and TLR2/4 LPS receptors. Activation of the CDI4 and TLR2/4 by bacterial derived LPS initiates a series of innate antimicrobial inflammatory responses. Innate inflammatory activities initiated by CDI4 and TLR4 activation by bacterial derived LPS include the production of a number of proinflammatory peptides.